Reduced Alzheimer's disease progression and neutrophil adhesion via competition using neutrophil-derived or engineered nanoparticles

PROJECT SUMMARY
Many Alzheimer’s disease (AD) drugs under development target aggregated amyloid beta (Aβ) peptide, but
this approach is controversial due to disappointing clinical outcomes. Thus, the need to develop new
therapeutic strategies for AD persists. Blood flow in the brain of Alzheimer disease patients is substantially
decreased as compared to age-matched healthy controls. Recently, intravital imaging with two-photon
microscopy showed that blood flow in AD mouse models is reduced because neutrophils plug up capillaries
resulting in a small, but impactful number of stalled capillaries. Removing these stalls by interfering with
neutrophil adhesion improves blood flow in minutes and also improves performance on tasks involving
short term or episodic memory within hours. Although this approach is promising because it targets blood
flow and inflammation, key features of AD unaddressed by amyloid-targeting drugs, it is currently limited to
experimental treatments with limited possibility for clinical translation. Existing experimental approaches
interfere with a protein not found in humans, Ly6G, or would cause severe compromise of the immune
system. This proposal aims to develop a novel strategy based on highly biocompatible neutrophil-derived
extracellular vesicles or nanoparticles that specifically target and block neutrophil adhesion sites in the
brain to reduce capillary stalls and the associated blood flow deficits. These novel agents are encapsulated
in neutrophil membranes that preserve many of the neutrophil functions so possess the same targeting
capacity as neutrophils. When injected systemically, these engineered particles compete with neutrophils
for binding sites on the brain capillaries, acting to reduce neutrophil arrest. Importantly, the particles are
only <1% of the size of neutrophils and do not cause capillary stalls. The proposed work will engineer and
characterize a novel AD therapy with the following Specific Aims: 1) Investigate the targeting of naturally-
derived neutrophil EVs (nEVs) that are generated from congenic mouse donors. This aim will follow up on
preliminary data that suggests these nEVs bind to capillaries in AD, but not wild type controls, and appear
to decrease capillary stall frequency while increasing cerebral blood flow. 2) Explore the therapeutic
potential of nEVs. Previous experimental capillary stall reduction strategies resulted in rapid recovery of
memory function, so it is expected that the novel nEVs would have a similar effect as assayed by working
and spatial memory tests. 3) Engineer neutrophil membrane-coated nanoparticles (NMPs) with cargo-
carrying capabilities. This aim will develop a second-generation engineered particle based on the same
neutrophil-membrane encapsulation as nEVs that could be loaded with drugs. This would provide the ability
to target therapies specifically to stall-prone capillaries in the brain. The proposed work combines expertise
in nanomaterials, extracellular vesicle biology, neurodegeneration, and in vivo multiphoton imaging to
develop a novel treatment for AD.

Public health relevance
Narrative We recently found a way of improving blood flow in the brains of Alzheimer’s disease mouse models that rapidly improves memory performance. However, the experimental compounds used are not practical for human patients. Here, we engineer novel nanoparticles that use the membranes of inflammatory cells as potential therapeutics for improving blood flow and cognition.